INTRAUTERINE TREATMENT OF HYDROCEPHALUS VIA FETAL VENTRICULAR AMNIOTIC SHUNT

Proposed treatment is an attempt to arrest the progress of hydrocephalus by venting excessive ventricular fluid to the amniotic space. By relieving pressure for a period of time in utero it is anticipated that additional fetal maturity can be achieved and the infant delivered near team. Definitive shunting would then be required.